Neoadjuvant Tucatinib plus Trastuzumab in HER2-amplified Locally Advanced Rectal Cancer

PROJECT SUMMARY/ABSTRACT
Current standard tri-modality therapy (chemotherapy, radiation, and surgery) for locally advanced rectal cancer
is associated with high morbidity and only cures disease in about 75% of patients. We hypothesize that a
biomarker-driven approach that gives matched targeted therapy to patients early in the treatment of locally
advanced rectal cancers will lead to high anti-tumor activity and provide the chance to avoid radiation and/or
surgery and its associated morbidities. We have already pioneered such an approach for mismatch repair
deficient locally advanced rectal cancer, where clinical complete response was seen in all patients who
completed 6 months of upfront treatment with immune checkpoint inhibitors (23/23, 100% complete clinical
response), allowing for the omission of radiation and/or surgery. In this proposal, we focus on patients with
HER2-amplified rectal cancer and hypothesize that induction therapy with HER2-targeted treatment will lead to
tumor regression and modify the need for tri-modality therapy. We propose an investigator-initiated phase II
study (NCT05672524; MSK IRB# 22-185) that recently opened to enrollment; all patients will receive tucatinib
plus trastuzumab induction HER2-targeted therapy for 6 weeks and continue tucatinib plus trastuzumab with
addition of standard-of-care chemotherapy for 4 months, followed by disease reassessment before standard
chemoradiation and before surgery. Patients with clinical complete response to induction HER2 therapy alone
or combined with chemotherapy, or to the combination followed by chemoradiation, will undergo observation
with a chance for an organ-sparing management approach. Our central hypothesis is that the primary tumor will
be highly sensitive to HER2-targeted therapy alone or in combination with standard chemotherapy, leading to a
higher frequency of clinical complete response than with standard total neoadjuvant therapy. Treatment of rectal
cancer in patients provides the unique opportunity to obtain on-treatment longitudinal tumor and blood samples
to evaluate mechanisms of response and resistance. We hypothesize that levels of HER2 expression and
consequent dependence on HER2 homodimers underlie drug response and will determine HER2 expression in
biopsy samples and with 89Zr-trastuzumab PET/MRI and correlate with response rate and progression-free
survival. Circulating tumor DNA will be tested as a biomarker for response. Established and newly generated
patient-derived HER2-amplified colorectal cancer organoids will be used to model and study acquired resistance,
taking advantage of our team's expertise in generating these three-dimensional, multi-cellular structures, which
both recapitulate the biology of rectal cancer and provide a needed resource that expands the limited HER2-
amplified rectal cancer models currently available. We hypothesize that key resistance mechanisms will consist
of decreased HER2 expression, secondary alterations that activate ERK, and shifts in tumor transcriptional
programs. Together, we will define the efficacy and biological effects of biomarker-directed therapy and aim to
transform treatment for patients with HER2-amplified locally advanced rectal cancer.

Public health relevance
PROJECT NARRATIVE We propose biomarker-directed therapy for patients with HER2-amplified locally advanced rectal cancer. In a clinical trial and associated correlative studies (using tissue and blood samples, HER2-targeting 89Zr-trastuzumab PET/MRI scans, and patient-derived organoid models), we will evaluate the efficacy and biological effects of HER2-targeted induction therapy, alone and with standard-of-care chemotherapy, to treat HER2-amplified rectal cancer. This therapy has the potential to transform the care of this molecularly defined subset of rectal cancer, omit radiation and/or surgery, and avoid the morbidity of standard-of-care tri-modality therapy.